Neuroscience Training Program

PROJECT SUMMARY/ABSTRACT
The long-standing Neuroscience Training Program (NTP) at the University of Wisconsin–Madison provides multi-
disciplinary, predoctoral graduate training in the neurosciences. The overarching goal of the program is to train
the next generation of leading integrative neuroscientists for careers in academia, healthcare, teaching, industry,
and public service. Graduate students in our program receive comprehensive, interdisciplinary research training
with internationally recognized faculty whose research interests span the breadth of modern neuroscience.
Indeed, students receive training in a broad range of neuroscience areas including: cellular and molecular
neuroscience; membrane excitability and synaptic transmission; neural circuits; systems and computational
neuroscience; perception and action; behavior, cognition, and emotion; development, plasticity, and repair; and
the neurobiology of disease. The proposed renewal of the T32 training grant includes a combination of hands-
on research, coursework, individual development plans (IDPs) and mentoring training, and a unique seminar
course. The NTP curriculum is designed to provide rigorous training that emphasizes sound scientific reasoning,
experimental design for neuroscience studies, as well as quantitative skills and statistical methodology taught
by NTP Faculty Trainers using neuroscience examples selected for their pedagogical value. Importantly, training
in responsible conduct of research (RCR) as well as rigor and reproducibility occurs throughout the entire training
period. The NTP Faculty Trainers include 93 members drawn from 24 departments. To student training, they
contribute expertise across a wide array of neuroscience subdisciplines and state-of-the-art methodologies
ranging from molecular genetics/proteomics to whole brain neuroimaging. New initiatives include expanded
mentorship training for our faculty and students; improved, student-tailored IDPs; and increased quantitative and
computational training. Newly focused efforts related to diversity and equity will emphasize recruitment and
retention of underrepresented minority (URM) students. These efforts will collectively advance the NTP’s goal of
fostering an environment of interdisciplinary neuroscience training that provides students with the intellectual
and experiential breadth necessary to advance biological and biomedical research as leaders in the field of
neuroscience. Our program has been particularly successful in achieving its training goals. Over the past 10
years, the average time to PhD was 5.19 years, the average number of first-author papers was 2.16, and the
average number of total papers was 5. Of our graduates 10-20 years post-degree, 34% hold tenure-track faculty
positions. We anticipate appointing 12 new T32 trainees per year. Selection of trainees will be based principally
upon prior academic and research accomplishments as well as demonstrated potential for an independent
research career. Graduates will be well-equipped to carry out research aimed at understanding fundamental
neurobiological processes as well as mechanisms underlying diseases and disorders of the nervous system,
and to train future generations of neuroscientists.

Public health relevance
PROJECT NARRATIVE The Neuroscience Training Program (NTP) at the University of Wisconsin–Madison provides integrated predoctoral neuroscience training, equipping students to carry out research aimed at understanding fundamental neurobiological processes and mechanisms underlying diseases and disorders of the nervous system. Our goal is to prepare our students to lead the next generation of scientists with independent careers in academia, healthcare, teaching, industry, and public service.